Developmental Research Project Core

MISSISSIPPI INBRE
DEVELOPMENTAL RESEARCH PROJECT PROGRAM
Project Summary/Abstract
In this renewal application, the MS INBRE will leverage extensive experience and successes within the unique
academic and cultural environment of Mississippi to significantly increase the number of competitive
biomedical investigators at primarily undergraduate institutions (PUIs) and enhance the overall biomedical
infrastructure in Mississippi. The MS INBRE's scientific themes focus on severe health challenges and
disparities in Mississippi – namely, cancer, infectious diseases, and obesity. The Developmental Research
Project Program (DRPP) for the MS INBRE is designed to grow the human capital within biomedical research
enterprises in MS through supporting investigators at partner PUIs, particularly Minority Serving Institutions
(MSIs), assisting with recruitment of outstanding junior faculty to PUIs, training students in biomedical
research, and providing opportunities for professional development. In particular, we will facilitate engagement
in research at the PUIs via working with leadership to release faculty from teaching, create or renovate
laboratory space, purchase and maintain equipment, and purchase research supplies. Support through the
DRPP has led to extramural funding, such as an R15 to Millsaps College, and numerous PUI peer-reviewed
publications. This program will specifically address these challenges/opportunities through the following three
specific aims: 1) Fund Project Development Grants (PDGs) and Research Initiation Grants (RIGs) to support
biomedical research and maximize student participation in research; 2) Provide Recruitment Funds to promote
the hire of accomplished, research-active junior faculty to PUIs; and 3) Provide venues for building a
community focused on excellence in research and a professional development opportunities to PUI
investigators. Our experience during the previous funding period has shown that such an approach will lead to
increase biomedical research at PUIs, recruitment of more research focused PUI faculty, and provide
additional direct hands-on research experiences for undergraduate students. These activities will also enhance
STEM courses with research components which will positively impact students for many years to come.

Public health relevance
Project Narrative: The Mississippi INBRE DRPP support biomedical research at the state's primarily undergraduate institutes. This will be accomplished by 1) providing funds to directly support meritorious research, 2) assist in the recruitment of outstanding researchers to their faculty, and 3) fostering professional development and a community of researchers.